Cortical contributions to frequency-following response generation and modulation

ABSTRACT: Frequency-following responses (FFRs) are scalp-recorded electrophysiological
‘neurophonic’ potentials that reflect phase-locked activity from neural ensembles across the
auditory pathway. FFRs provide a neural snapshot of the integrity of supra-threshold speech
processing that can be measured non-invasively using a minimal electrophysiological set-up that
already exists in audiology clinics, has high test-retest reliability, and requires minimal subject
preparation. The original project, titled “Online modulation of auditory brainstem responses to
speech”, examined the extent to which FFRs, which were thought to primarily reflect subcortical
auditory processing, were influenced by experience-dependent plasticity. The previous proposal
systematically tested a predictive tuning model that proposed that subcortical auditory processing
is not hard-wired in adults, and that there is continuous fine-tuning of the representation of
stimulus features guided by top-down expectations. An evolving perspective is that the FFR
should be considered an integrated response from both subcortical and cortical neural
ensembles. There is a critical need to understand cortical contributions to the FFR to realize the
fundamental translational potential as a biomarker for many clinical conditions. In this renewal
application, the primary focus is to understand the properties of the cortical source of the FFR at
a mechanistic level, as well as the larger role of cortico-collicular modulatory influences on the
FFR. Using a highly complementary and cross-disciplinary team of PIs, this proposal builds on
key scientific insights gained in the first funding period with the explicit goal of accelerating pre-
clinical to clinical translation. Using a cross-species (human, macaque, guinea pigs), cross-level
(cells to meso-scale), neurocomputational approach, this proposal systematically deconstructs
the role of the cortex in the generation and modulation of the FFR. Aim 1 will measure scalp-
recorded FFRs and intracranial cortical activity in human patients, macaques, and guinea pigs to
characterize cortical phase-locking limits, laminar and frequency dependence, and hemispheric
asymmetry. Aim 2 will measure scalp-recorded and intracranial FFRs to human and non-human
vocalizations using a harmonized protocol in all three species. Using representational similarity
analyses to quantify cross-species and cross-level similarities, Aim 2 will examine the influence
of predictability, category relevance, and subject arousal on the FFRs. Aim 3 leverages this
information to build a novel computational model that consists of a core feedforward module
that is modulated by a feedback cortico-collicular module. Predictions from this model will be
systematically validated in human patients with Heschl’s gyrus lesions, and using chemogenetic
experiments to reversibly suppress cortico-collicular feedback in animal models.

Public health relevance
PROJECT NARRATIVE The frequency-following response (FFR), a scalp-recorded neurophonic potential, is a widely-used metric of speech encoding integrity in healthy and clinical human populations. The translational potential of the FFR as a biomarker is constrained by poor understanding of its neural generators. This proposal leverages a cross-species and cross-level approach to provide mechanistic insight into the properties of the cortical source of the FFR, and elucidate the role of cortical feedback via cortico-collicular projections on modulation of the FFR as a function of stimulus context, arousal state, and category relevance.